Use of Long-Acting Reversible Contraception

PROJECT SUMMARY
This K23 Award will provide Dr. Jenny K Rodriguez Francis support to: (1) gain a strong grounding in the
science of adolescent contraceptive decision-making; (2) acquire advanced training in mixed-methods; and (3)
learn and apply intervention development approaches to translate observational findings into communication-
focused interventions. To achieve these goals Dr. Francis has assembled a mentoring team and advisory
committee spanning multiple disciplines and institutions. Her primary mentor, Jasmin Tiro, PhD, has an
excellent track record of research funding and mentorship and is an expert in adolescent health promotion,
mixed-methods, intervention development and patient-provider communication. Dr. Francis’ next mentor is
Susan L. Rosenthal, PhD, internationally renowned for adolescent-parent communication, acceptability of
vaccines and microbicides, mixed-methods, faculty development and mentoring junior faculty to become
independent investigators. Dr. Francis’ advisory committee includes: Simon Craddock Lee, PhD, MPH, an
expert of implementation science and qualitative methods; Melanie A. Gold, DO, a well-published expert in
LARC for adolescents; and Nancy Kelly, MD, MPH, a community pediatrician who partners closely with local
schools. Problem: Texas has the fifth highest rate of teen births in the nation, with 33,144 females under age
20 years giving birth last year. LARC (intrauterine devices and contraceptive implants) is the first line method
for contraception for adolescents/young adults; yet uptake is sub-optimal. Interventions designed to increase
uptake have insufficiently considered the provider’s communication with adolescents and mothers to initiate
contraception. Informed by Dr. Francis’ prior research assessing discordance between adolescent-parent
dyads and her clinical experience, this mixed methodology proposal will examine these gaps in knowledge to
enhance the development of interventions to foster LARC uptake. Specific Aims seek to (1) characterize
medical providers’ (pediatric house staff) knowledge of and communication about LARC when discussing with
adolescent-mother dyads; (2) describe adolescents’ and mothers’ beliefs about the optimal ways that providers
can support contraceptive decision-making among adolescents. Methods: For aim 1, we will recruit 200
University of Texas pediatric house officers to complete a brief online questionnaire. For aim 2, we will
evaluate adolescents’ beliefs, mother’s beliefs, and their dyadic interactions about their contraceptive
counseling preferences through separate semi-structured interviews with 30 adolescents, 30 mothers and 30
adolescent-mother dyads (90 interviews total). Outcomes: These hypothesis-generating mixed-methods
findings will provide a strong grounding in the science of adolescent contraceptive decision-making to design a
future communication-focused intervention tool to support LARC uptake. Results could also improve
subspecialists’ ability to prevent pregnancy among adolescents with chronic conditions. This study impacts
provider communication, addresses maternal needs and supports adolescent contraception decision-making.

Public health relevance
PROJECT NARRATIVE The most reliable and effective method of birth control available for adolescents is long acting reversible contraception (LARC), yet LARC is the method of birth control least used by adolescents. Interventions to address poor uptake have failed to adequately consider provider’s communication in discussing LARC, and what adolescents and mothers expect from their provider when counseled about birth control options. Understanding the decision-making process among an adolescent-mother-provider triad will provide the necessary foundation to develop future communication-focused interventions targeting the triad.